Role of NLRP3 signals in ischemia/reperfusion-induced organ injury

Project Summary: This proposal evaluates how the cytoplasmic innate immune receptor, NOD-, LRR- and pyrin
domain-containing protein 3 (NLRP3) contributes to chronic kidney disease (CKD) after SARS-CoV2 infection of
human and murine kidneys. The project is highly significant for understanding the steps leading to chronic renal
injury associated with COVID-19 disease.
Broad/long-term objectives: The long-term goals of the proposed research are to define how activation of NLRP3
contributes to chronic injurious tissue responses in human kidneys following SARS-CoV2 infection.
Specific Aims: The central goal of this proposal is to test the hypothesis that SARS-CoV2 infection triggers cell-
type specific responses that affect the NLRP3 pathway, and that dysregulation of this pathway contributes to the
pathogenesis of CKD as a post-acute sequalae of COVID-19 disease.
Research Design and Methods for Achieving the Stated Goals: Aim 1 will examine the effect of SARS-CoV2
infection on NLRP3 pathway activation and its functional consequences in human and murine renal tubular epithelia
and will test consequences of blockade. Aim 2 will examine how SARS-CoV2 infection induces chronic kidney
injury using two murine models of infection, and tests whether blockade of NLRP3 signaling pathways prevents that
injury. Aim 3 will examine the consequences of NLRP3 pathway activation and blockade in SARS-CoV2 chronically
infected human kidney organoids.
Health Relatedness of Project: If the aims of this proposal are met we will learn how activation of NLRP3
contributes to the pathogenesis of the post-acute sequalae of CKD after COVID-19 disease. This knowledge is
crucial for the development of rational target therapies for prevention or amelioration of organ injury following SARS-
CoV2 infection.

Public health relevance
Project Narrative: Severe COVID-19 disease is marked by a hyperinflammatory state involving specific organs, such as the lungs and kidneys and evidence indicates that engagement of multiple innate immune pathways, including those regulated by the intracellular innate sensor Nod-, LRR- and pyrin domain-containing protein 3 (NLRP3), contribute to the acute and chronic pathologic manifestations of COVID-19. There are major gaps in our knowledge about the regulation and role of the NLRP3 pathway following SCoV2 infection, and this project addresses these gaps to better understand the mechanisms of SCoV2-induced chronic kidney disease (CKD ), which is an increasingly recognized post-acute sequalae in COVID-19 patients.